Cue-101 and TCR-T cell Combinatorial Strategy for HPV+ Head and Neck Cancers

PROJECT SUMMARY
Human papillomavirus (HPV) is the causative agent of a growing proportion of incident cases of head and neck
squamous cell carcinomas (HNSCCs). HPV type 16 is responsible for over 90% of HPV+ HNSCCs diagnosed
in the United States. The HPV16 E7 antigen is an attractive immunotherapeutic target for HPV-associated
cancers since it is a unique virus-specific oncoprotein constitutively expressed by all cancer cells. T cells that
are genetically engineered to express an HLA-A*0201-restricted T cell receptor (TCR) that recognizes the
HPV16 E711-19 epitope can mediate regression of HPV16-associated cancers in a preclinical model.1 A phase 1,
first-in-human (FIH) multi-center study demonstrated the safety and efficacy of an autologous HPV TCR-
engineered T cell (TCR-T) therapy which targets the HPV16 E7 binding epitope in HLA-A*0201-expressing HPV+
cancer patients (NCT03912831).2 However, the realized challenges with adoptive cell therapy (ACT) are: i) the
high costs associated with manufacturability and monitoring and managing the toxicities from the supra-
physiological bolus of ACT products which are combined with systemic IL-2 administration, and ii) the limited in
vivo persistence due to the lack of appropriate antigen-specific stimulation due to poor intra-tumoral T cell
recruitment into solid tumors. Herein, we propose innovative proof-of-concept (PoC) experiments to determine
whether a low dose of adoptively transferred HPV16 E711-19 TCR-T cells can be exponentially expanded in situ
by administering a novel biologic fusion protein, CUE-101, which delivers the HPV16 E7 antigen-specific
stimulation with localized delivery of high doses of IL-2.3-5 Furthermore, we determine whether HPV16 E7 TCR-
T cell persistence translates into an enhanced anti-tumor effect in preclinical HPV+ tumor models (Aim 1). Lastly,
we build upon our team’s discovery of the role of the CXCR6:CXCL16 axis in the recruitment of peripheral
circulating CD8+ T cells to perivascular niches of the tumor populated by CXCL16-expressing CCR7+ DC3s,
which can sustain the survival of tumor-specific CD8+ T cells.6 Thus, we assess whether the efficacy of HPV16
E7 TCR-T cells can be improved through engineering strategies that introduce CXCR6 to the TCR-T cells, which
can facilitate intra-tumoral recruitment, proliferation, and survival in situ (Aim 2). The completion of these aims
will generate the supporting rationale for a future clinical trial administering HPV16 E7 TCR-T cells and CUE-
101 in HPV+ cancer patients. These efforts can potentially transform our current approaches to adoptive cell
therapy.

Public health relevance
PROJECT NARRATIVE Several challenges exist that limit the realized potential of cell-based therapies in the setting of solid tumors, including high manufacturing costs, poor intra-tumoral recruitment, and limited expansion of adoptively transferred cellular products. Utilizing HPV-associated cancers as a model system, we propose innovative concepts and engineering strategies to facilitate in situ proliferation of adoptively transferred T cells that can potentially transform our approach to adoptive cell therapies.